Community Operations

The overall goal of the Community Interactions and Outreach Core will be to develop and implement a robust program so that the data generated by the DTSGC can be widely disseminated and critically analyzed by a many extramural researchers, both experimental and computational in academia as well as industry. For this we plan to have a multi-faceted approach that involves software development and release as well as educational activities both online and in person. We will develop a website that will serve as the gateway for all of the experimental and computational data generated by the DTSGC. We will use this website to provide a range of services to the community and to receive input from the community. As part of these outreach efforts we plan to develop computational and visualization tools for sharing the raw and processed data with the community at large and the LINCS Data Coordinating Center. All of the experimental and computational data will be shared on an ongoing basis with releases every month or every two months. Data release will be integrated both conceptually and temporally with web -based educational and instructional materials. We will also make available cloud computing capability so that our data can be analyzed using our tools by others with different perspectives. We anticipate three major classes of consumers for this data: biomedical researchers in academic institutions; computational researchers in both academia and industry; and drug discovery and drug action focused researchers in industry. We will develop web-based tools for data visualization and de novo analysis so that each class of researchers can fully utilize the data we generate. We will run web-based courses using Coursera for data utilization and development of signature-based research projects. We will also have series of mini-courses on our Center website. We will conduct 4-6 personalized workshops to enable academic researchers to utilize our signatures to develop research projects that can compete for individual research grant funding. We run workshops for industry researchers so that the Center can interact with them in both precompetitive and competitive space. All of these outreach activities together should enable the DTSGC to have a broad and deep impact on the pharmacology and therapeutics research community.

Public health relevance
RELEVANCE (See instructions): We propose to develop a research center that will use experiments and mathematical modeling to obtain signatures for drug induced adverse events and the mitigation of such events by second drugs.